Large Scale Antibody and T Cell Epitope Discovery Program

The Large Scale Antibody and T Cell Epitope Discovery Program will support large scale discovery of novel B and T cell epitopes that utilize recent technological advances. In addition, the program will develop new or improved high throughput screening methods for epitope discovery, with a strong interest in antibody epitope screening methods. This program emphasizes epitope discovery for category A-C bioterrorism agents and emerging/re-emerging infectious diseases.